LOW FAT DIET AND BREAST CANCER RECURRENCE, OUTCOME TRIAL

To evaluate the effects of nutrition as an addition to a treatment or follow-up program for breast cancer patients following surgery. To determine adherence to a program involving significant dietary alteration including dietary fat reduction.